Administrative Core

REVISED ABSTRACT:
Administrative Core: Project Summary – 2P30AG066530-06 (5765)
The Administrative Core will provide the leadership, administrative mechanisms and oversight to enable the USC ADRC to achieve its overall aims and foster core interactions of the center. By providing a clear and transparent mechanism for communication, resource allocation, budget management and insuring all regulatory and participant safety processes are adhered to, the Administrative Core will further the overall missions as described in each of the components of this proposal. The Administrative Core has 4 specific aims: 1) Guide the scientific direction of the ADRC around its three overarching scientific goals to recruit and follow a clinical cohort that is enriched for carriers of APOE ε4, promote local ADRD research at USC, and further national collaborations, 2) Coordinate fiscal, operational, and regulatory functions across all cores to ensure appropriate, optimal, and effective utilization of center resources.3) Promote participation across all Cores in collaborative national research initiatives, including
NACC, NCRAD, ADGC, ADNI, ACTC, DVCID, ACAD, SCAN, and CLARiTI, leveraging our metabolic,
vascular disease, and neuroimaging expertise to clarify factors that modify the effect of APOE ε4 on cognitive decline and AD biomarkers, 4) Attract early-stage and new investigators, and Support Training and Education through mentorship, development projects (DP), seminars, and research symposia and provide public education on the importance of understanding and addressing genetic, metabolic and vascular risk profiles for brain health.